Microglial contributions to the development of the mammalian optic stalk

Project Summary
Ocular development is marked by a key embryonic process, the closure of the ventral optic fissure. Failure in
the proper closure of the optic fissure results in coloboma, a cause of significant visual impairment. Microglia,
the resident innate immune phagocyte of the central nervous system, are found to populate the retina prior to
the closure of the optic fissure. Microglia are specialized to recognize and eliminate apoptotic cells, and
critically, cell death is associated with optic fissure closure in mouse and human. It is unknown, however,
whether microglia participate in the proper closure of the optic fissure in mammals.
To address this, Aim1 will determine whether microglia facilitate optic fissure closure through elimination of
apoptotic cells. I will collect tissue from Bax-/-, MerTK-/-, and Pu.1-/- embryos, and their littermate controls, at
onset of optic fissure closure, during optic fissure closure, and following optic fissure closure. These mouse
lines will allow me to test whether blocking developmental apoptosis, blocking microglial recognition of
apoptotic cells, or eliminating microglia completely alters optic fissure closure. Aim2 will determine the
expression profile of optic fissure-associated microglia during closure. I will collect tissue from Cx3CR1GFP/+
mice during optic fissure closure and determine the gene expression profile of optic fissure-associated
microglia versus adjacent ventral retina microglia using in situ hybridization chain reaction (HCR).
While I have a strong background and laboratory experience in neuroscience, both in the context of
development and disease, I require additional training to develop as an independent researcher. My goals as a
graduate student are to build strength in neuroimmunology and techniques and tools to study contributions of
immunology to neurodevelopment. This foundation will prepare me to pursue my long-term career goal of
becoming a research scientist. I anticipate that my preliminary data plus the aims described here will produce
at least one scientific manuscript while also supplying preliminary data for future grant applications. Under the
training plan provided by this fellowship, will refine technical skills, deepen my expertise in neuroimmunology,
and become independent in experimental choice, design, analysis, and communication. These skills will propel
me on my trajectory towards a career as an independent researcher. Completion of this work will define how
microglia shape the closure of the optic fissure and contribute to the embryonic development of the retina and
optic nerve. This proposal aims to address the role of microglia in mammalian optic fissure closure, yielding
insights into pathways involved in optic fissure closure, and more broadly, revealing how microglia regulate
tissue morphogenesis.

Public health relevance
Project Narrative Understanding the pathways mediating mammalian optic fissure closure is essential for defining processes of development and disease in retinal development. Microglia, the resident immune cell of the central nervous system, have been shown to be a dynamic, influential participant of many developmental processes. However, their precise roles in many of these processes are not well understood. Utilizing the embryonic eye, I aim to define the role of innate immune pathways utilized in mammalian ocular morphogenesis, providing a novel insight that may be relevant for mechanisms underlying coloboma.